Large-scale production and purification of biological compounds

A significant portion of the Units activities is the production of high-quality and unique biologicals that are not available from commercial sources. On average, the Unit performs between 150 to 200 processes per year, which include fermentation of bacteria, yeast, insect cells, and mammalian cells (in volumes ranging from 2 to 200 liters), and recovery and purification of biomolecules, such as proteins and polysaccharides, from different sources. The following are examples of processes performed: growth of bacteria like Escherichia coli, (recombinant and native), Corynebacteria diphtheria, Salmonella, Shighella, Staphylococcus, Haefmofillus influenzae, Bacillus Anthracis, and various recombinant yeast strains like Saccharomyces cerevisiae and Pichia pastoris. In addition, mammalian cells such as HeLa, CHO, BHK and HEK 293, and insect cells like Sf 9, and High five for transient expression of recombinant proteins were propagated. Several proteins were produced and purified in gram quantities. Examples are: recombinant Pseudomonas aeruginosa exotoxin A, and human adiponectin. [unreadable] The various products were needed for a number of collaborative research projects: the preparation of immunotoxins for the treatment of specific types of cancer and T cell depletion, human adiponectin was made for biological studies and several proteins were produced for structural studies among them Toll proteins and G protein-coupled receptors.